SC COBRE FOR DEVELOPMENTALLY BASED CARDIOVASCULAR DISEASES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. For investigations into the molecular defects that cause mitral valve diseases. This research will help scientists better understand the pathogenesis and potentially lead to rational translational therapies.